MATERNAL ZINC STATUS DURING LACTATION GROWTH OF THE BREAST FED INFANT

Objective is to study prospectively patients with Kawasaki's disease in an attempt to learn about the etiology, pathophysiology and therapy of this disease.